The hsp90 Cochaperone FKBP51 Regulates tau Structure and Function

Project Summary/Abstract
Neuropsychiatric symptoms (NPS), like depression, are common early in Alzheimer’s disease (AD) and
correlate with a faster decline in patients. NPS and cognitive deficits in AD have been linked with the
accumulation of tau protein. Two independent studies associated an allelic variant in the 51kDa FK506-binding
protein (FKBP51) with increased risk for depression in AD. FKBP51 also regulates tau accumulation and toxicity
to nerve cells. We will use transgenic mouse models to determine if either removing or inhibiting FKBP51 in mice
will be protective against tau accumulation. We will also study whether mice that have this risk variant in
combination with tau accumulation are more vulnerable to NPS. The critical knowledge gained through this work
will add to our understanding of the role of FKBP51 in regulating tau pathogenesis especially during disease
progression. This work will have a positive impact in AD research as we will further validate FKBP51 as a target
and characterize the molecular landscape associated with vulnerability to NPS in tauopathies.

Public health relevance
Project Narrative A molecular chaperone that regulates the abnormal accumulation of the microtubule associated protein tau in the brain has now been linked to the neuropsychiatric symptoms in Alzheimer’s disease (AD). This project will determine if targeting this protein can be protective and explore the molecular pathways that may underly the link to depression in AD.